Identification & Evaluation of Novel Malaria Anti-Gametocyte Transmission Blocking Vaccine Candidate Antigens

The overall goal of this application is to identify and describe novel candidate antigens for an anti-gametocyte
transmission blocking vaccine (TBV) for human falciparum malaria. The development of malaria vaccines that
reduce transmission of the parasite and thereby substantially reduce the incidence of human malaria (parasite)
infection has been widely recognized as a pivotal determinant of the success of future malaria control efforts.
Vaccines to interrupt transmission have classically focused on interrupting gamete fertilization and ookinete
invasion events in the mosquito vector. However, an alternative target exists, ie, the reduction of gametocytes
(the transmissible form of malaria) in the human host. Evidence to support the feasibility of developing an anti-
gametocyte as compared to an anti-gamete TBV springs from longitudinal field studies that have
documented the acquisition of antibodies to gametocyte-infected erythrocytes in children and adults, and
critically these antibodies were correlated with decreased gametocyte densities. Mosquito infection prevalence
has also been found to decrease at low gametocyte densities, suggesting that vaccine-induced decreases in
human gametocytemia may contribute to transmission blocking efforts by decreasing mosquito infection.
In this proposal, we will apply our whole proteome differential screening platform to interrogate the gametocyte
proteome with already collected plasma from Kenyan adolescents/adults with and without resistance to
peripheral microscopic gametocytemia (as well as from a second cohort of Kenyan children in which we will be
able to quantify sub-microscopic gametocytemia) to identify parasite genes that encode proteins uniquely
recognized by the plasma of individuals resistant but not susceptible to gametocytemia. We hypothesize that
a subset of these antigens, elicit antibodies that regulate gametocyte density. In preliminary data
generated for this grant, we have already identified a unique gametocyte antigen, antibodies to which
(measured at the start of the high transmission season) predict significantly lower gametocytemia over the 18-
week transmission season (P = 0.021) in our Adolescent-Adult Kenyan cohort (JID, 2018).
To complete our anti-gametocyte vaccine antigen discovery and validation process, we propose the following
specific aims; 1) To identify additional novel anti-gametocyte TBV candidate antigens using our differential
whole gametocyte proteome screening platform and relate antigen specific IgG responses to resistance to
gametocytemia in two independent Kenyan cohorts, and in 2) we will validate antigens identified in SA1 as
suitable TBV candidates based on cellular location, surface expression and ability to elicit gametocyte
controlling immune responses in in vitro assays.
The deliverables of this application will include the identification of gametocyte specific antigens which are the
targets antibodies that control gametocytemia. The discovery and validation of these antigens, will represent a
landmark achievement on the path towards the development of an anti-gametocyte TBV.

Public health relevance
Malaria is a deadly disease responsible for tremendous global mortality and morbidity, primarily in children under the age of five. Targeting transmission has been identified as a critical component of the success of future malaria elimination/eradication efforts. In this proposal, we will specifically target the transmissible form of the parasite, or gametocytes, which reside within the human host waiting to be picked up by a biting mosquito. We expect to identify and validate numerous novel anti-gametocyte transmission blocking vaccine candidate antigens which are the targets of gametocyte controlling humoral responses.